Mammary Carcinoma and Genomic Methylation Patterns

DESCRIPTION (provided by applicant): We have developed a new technology that provides whole-genome methylation profiles. The new technology has large advantages in coverage, simplicity, accuracy, and economy over other methods. The approach combines a new method of enzymatic fractionation of DNA into methylated and unmethylated compartments and the application of emerging technologies in ultrahigh throughput DNA sequencing to profile genomic methylation patterns. We will determine sites of demethylation and de novo methylation in the genomes of a panel of cell lines derived from mammary carcinomas and of a large panel of primary mammary carcinomas that are well-characterized in terms of histopathology and expression of molecular markers. Whole-genome methylation profiling of DNA of 2 ductal carcinomas and adjacent normal tissues has been completed, as has a complete methylation profile of the mammary carcinoma cell line MCF7. We will then use fully-implemented computational methods to identify those methylation abnormalities that are most highly correlated with type, grade, and stage of mammary carcinomas. The goal is a set of diagnostic and prognostic criteria that can be used in the development of biomarkers for mammary carcinoma. A diagnostic procedure will be developed that will test for de novo methylation and demethylation of the sequences found to be most often hypermethylated in mammary carcinoma, and a simple and novel method for the evaluation of methylation abnormalities in biopsy DNA is described. Our preliminary results, together with some long-standing enigmas in the literature, lead us to propose that the methylation abnormalities so common in mammary carcinoma may reflect the operation of a system (the methylation suicide system) that kills cells that have lost growth control.

Public health relevance
Narrative) We)will)perform)the)first)genome-wide)methylation)profiling)of)the)human)genome) to)catalog)the)methylation)abnormalities)that)occur)in)mammary)carcinoma.))Our) methylation)profiling)method)is)superior)to)competing)methods)by)an)order)of) magnitude)and)is)the)only)method)that)can)address)the)methylation)status)of) repeated)sequences.)We)have)already)profiled)two)mammary)carcinoma)genomes) (one)of)a)luminal)A)type)and)one)of)a)basal-like)type))and)have)found)that)tumor) suppressor)genes)are)no)more)likely)than)other)genes)to)acquire)methylation)over) their)promoters.))We)provide)preliminary)evidence)in)the)form)of)many)millions)of) sequences)to)both)provide)a)robust,)economical,)and)state)of)the)art)solution)to) whole-genome)methylation)profiling.))The)preliminary)results)cause)us)to)challenge) the)prevailing)epimutation)model,)which)ascribes)a)major)role)to)de)novo) methylation)of)tumor)suppressor)promoters)in)human)cancer.))We)also)develop)the) first)genome-wide)and)unbiased)approach)to)the)discovery)of)biomarkers)that)will) be)useful)in)the)early)detection)of)mammary)carcinoma.)